Development of real-world motor outcome measures in ataxia-telangiectasia

Abstract
Objective, sensitive, and clinically meaningful assessments of disease severity are needed in ataxia-
telangiectasia (A-T) and other neurological disorders to support drug development efforts, facilitate clinical
care, and provide caregivers and patients with real-time information about disease status. This need has
become even more critical as the number of disease-modifying therapies under evaluation rapidly expands.
Daily fluctuation in symptoms, superimposed changes related to child development, and variable participation
in task-based assessments pose challenges to precisely measuring disease severity. Passive and continuous
(i.e., task-free) collection of movement data at-home using consumer-grade wearable sensors, combined with
motor control theory-inspired signal processing and machine learning methods, provides an opportunity to
produce reliable, interpretable, and meaningful motor measures that can sensitively capture disease change.
We have recently made substantial preliminary progress in creating algorithms to extract and
characterize movement building blocks called “submovements” from a single wrist or ankle sensor worn
continuously at home. These sensor-based features show strong potential as novel disease measures: they
demonstrate high reliability, correlate with clinician assessments of motor severity and caregiver-reported
motor function, and show potential to sensitively quantify disease progression. By passively measuring
everyday activity, the information obtained can be more ecologically valid and comprehensive than task-
specific measurements and is applicable in young children as well in older, non-ambulatory individuals. We
propose to further develop and expand this technology over a wide age range and in a longitudinal cohort of A-
T and age- and gender-matched control participants to establish reliability, age relationships, and sensitivity to
disease change. Additional clinical, caregiver-reported, and molecular data will be obtained alongside wrist and
ankle sensor data to increase the interpretability and clinical meaningfulness of the measures and move
toward clinical trial-ready outcome measures.
The overall goal of this project is to develop accessible technologies that produce highly sensitive,
meaningful, and ecologically-valid measures of motor function for use in clinical trials and clinical practice in A-
T as well as other pediatric and adult neurodegenerative disorders.

Public health relevance
Project Narrative Promising disease-modifying therapies are being developed for ataxia-telangiectasia and other pediatric neurological diseases, but current assessment tools are very insensitive at determining efficacy, resulting in large and expensive trials. This project aims to develop precise motor outcome measures, using inexpensive and widely accessible digital technologies, that can sensitively determine if a therapy is effective in children of all ages.